Lateralization of posterior-parietal cortex contributions to motor learning

Project Summary:
Motor learning is fundamental for humans to become proficient in daily activities, such as self-care, work, and
leisure. Two fundamental components of motor learning in humans, motor adaptation and skill learning, are
critical for acquiring new activities. For example, when learning a new sport, such as pickleball, one adapts
previously learned tennis skills (adaptation) while also learning components unique to the sport at hand (skill
learning). This proposal details a set of studies aimed at understanding the functional neuroanatomy of
these two learning processes. Converging evidence implicates a major role of posterior parietal cortex (PPC)
in visuomotor learning. We have previously shown that left, but not right, posterior parietal lesions in stroke
patients prevent motor adaptation with both the contralesional and ipsilesional arms, indicating that learning is
lateralized to the left hemisphere. This proposal will utilize two types of non-invasive brain stimulation (NIBS) in
humans to ask the following questions: Are there hemisphere-specific effects on the two types of motor
learning?, and can learning and/or transfer be facilitated by excitatory stimulation to posterior parietal
cortex? We will examine interlimb transfer of learning as a reflection of consolidation of effector-independent
motor memories. Our overarching hypothesis is that HD-tDCS delivered exclusively to the left PPC will facilitate
learning and/or transfer in each of the adaptation and skill learning tasks, and that this facilitation will be plausibly
attributable to motor consolidation between trials. We will test these hypotheses through three aims that address
1) whether anodal high-definition transcranial direct current stimulation (HD-tDCS) delivered to left, but not right,
posterior parietal cortex will facilitate visuomotor adaptation and interlimb transfer in both arms, 2) whether
anodal HD-tDCS delivered to left, but not right, posterior parietal cortex will facilitate skill learning and interlimb
transfer in both arms, and 3) whether double pulse TMS delivered to the left, but not the right, PPC, either prior
to movement or during movement, will affect learning and transfer in both tasks. This last aim will help to elucidate
the mechanisms underlying posterior parietal cortex mediated learning. Our pilot data strongly support a
substantial effect of NIBS to the left PPC on distinct aspects of these two motor learning processes. The
information gained from this study should prove essential for the optimal translation of non-invasive
brain stimulation techniques to motor learning in rehabilitation. This proposal brings together the
complimentary expertise of two research programs: Dr. Sainburg has developed the proposed behavioral
paradigms, related software/hardware, and his team has expertise in the neural basis of motor control, learning,
and lateralization. Dr. Tunik studies the neural foundations of visual-motor coordination for upper limb
movements. His team has specific expertise in the brain stimulation techniques proposed. Both teams have been
effectively working together for over a year.

Public health relevance
Project Narrative: Motor learning is fundamental for humans to become proficient in daily activities and includes two fundamental components, motor adaptation and skill learning, which are both critical for learning new competencies in daily life and in rehabilitation. This study will use non-invasive brain stimulation to examine the neural mechanisms that underlie motor learning, including whether both components of learning are lateralized to the left brain-hemisphere. The information gained from this study should prove essential for the optimal translation of non-invasive brain stimulation techniques to motor learning in rehabilitation.